WHO COLLABORATING CENTER FOR INVESTIGATIONS IN DIABETES

The WHO Collaborating Center for Design, Methodology and Analysis of epidemiological and Clinical Investigations in Diabetes was designated in 1986. The purposes of the Center are to collaborate with the World Health Organization in the implementation of the WHO/IDF action program to provide advice, consultation and collaboration with other investigators in the design, methodology; and analysis of epidemiology and clinical investigations relating to the etiology and pathogenesis of non-insulin dependent diabetes (NIDDM) and its complications. The center will assist in the development and application of standardized methods for epidemiological and clinical investigations, and data analysis relating to diabetes and collaborate with those interested in applying such techniques elsewhere. The Center will advise and help in the design of new studies, including onsite assistance when necessary. The center serves as a central laboratory for the WHO Multicenter Study of Vascular Disease in Diabetes, as well as being a participating study center for this study which is examining the mortality and incidence of vascular complications of diabetes among different ethnic groups in different countries. In addition the center has initiated a collaborative study of impaired glucose tolerance in China, and is collaborating in the preparation of a survey manual for diabetes mellitus on behalf of WHO.